Alzheimer's Disease in Native Hawaiians and Pacific Islanders: Sample Acquisition and Whole Genome Sequencing

Project Summary
Alzheimer’s disease (AD) is among the most significant public health and medical challenges of our day. Approximately 7
million Americans are living with AD, and without effective interventions, the number will double in the next 25 years.
Homogenous datasets limit the clinical utility of discoveries, possibly leading to race-based disparities in therapeutics and
diagnostic tools. Almost all AD research data were derived from majority-White populations in high-income countries.
Native Hawaiians and Pacific Islanders (NHPIs) have exceptionally high risk. Yet, despite being the second
fastest-growing racial minority group, NHPIs are the least represented racial minority group in large repositories/datasets.
The ADSP was initiated, in part, to solve the genetic architecture of AD. While limited data exist, available evidence
suggests that the genetic architecture of AD in NHPIs is unique. For example, the APOE SNPs are not correlated with AD
in Chamorros or Polynesians. We plan to do the following. Aim 1. Recruit and Collect Data from 5,000 NHPIs. We will
recruit 1,000 NHPIs annually through our network of connections, including community and religious leaders, social
media, radio, TV, personal connections, and word of mouth. Each participant will complete thorough health, medical,
social determinants of health, diet, physical activity, and demographics surveys; a neurophysical exam; provide a blood
sample; and AD testing. We will collect whole genome sequences, SNP Array data, and standard laboratory assays for
each participant. Aim 2. Participant Diagnosis. Each participant will be diagnosed using the NACC battery and
adjudicated following the protocols established by ACAD with minor adaptations to make the assessments culturally
appropriate for NHPIs. Aim 3. Genetic Analyses. We will describe NHPI genetics (e.g., estimate SNP frequencies in
NHPIs), analyze NHPI population structure, and conduct the first AD GWAS in NHPIs.

Public health relevance
Project Narrative Native Hawaiians and Pacific Islanders (NHPIs) are absent from Alzheimer’s disease datasets, biobanks, and research. Yet, several factors indicate that NHPIs are likely affected at higher rates than other races and are affected by more co-morbidities. Our proposed work, a collaboration with NHPIs, will lead to the representation of NHPIs in Alzheimer’s research.